Integrated Mentored Patient-Oriented Research Training (IMPORT) in Psychiatry

Parent R-25 Abstract
Declines in the numbers of physicians pursuing careers in patient-oriented research
have raised national concerns about an impending crisis in public health care. While numerous
medical fields are affected, the problem in psychiatry is particularly acute, with projected
shortages prompting an analysis of the problem by the Institute of Medicine. Ironically,
shortages of psychiatrists pursuing patient-oriented research careers occur at a time when
discoveries in the fields of genetics and neuroscience are having an unprecedented impact on
our understanding of behavior. Translating such basic science insights into discoveries in the
patient-care realm will be crucial for improving our understanding and treatment of several
mental illnesses. The current R25 renewal is intended to further address the current crisis in
mental health research education through several specific aims, aims that build upon prior
success of the past 17 years. These include 1) continuing to educate psychiatry residents under
established (“traditional”) model of Integrated Mentored Patient-Oriented Research Training
(IMPORT), 2) building upon this model through the addition of a modified (“early immersion”)
track that is designed to better accommodate trainees with greater research experience and
respond to increasingly complex translational research methods, and 3) augmenting both
models by the addition of early (PG1) elective time, mentoring committees, educational
experiences in grant writing (including opportunities for securing pilot funding), and enhanced
recruitment. If successfully renewed, the program will continue to benefit the nation, through the
increased identification, recruitment and retention of a highly skilled cadre of patient-oriented
psychiatric physician scientists, and by piloting and implementing a flexible, individualized model
of research education for psychiatry residency programs nationally.

Public health relevance
In order to further our efforts to create an increasingly diverse and inclusive national psychiatric physician-scientist workforce, we propose a summer research experience that will allow qualified and motivated medical students from diverse backgrounds to gain direct exposure to academic research in the field of psychiatry. This program will not only provide an experience that is designed to further entice, encourage and bolster students' applications to psychiatry residency training programs, it will provide opportunities for publication and first hand exposure to Yale residents and faculty (including numerous leaders in the field). Through this program, we will create another mechanism to improve the recruitment and retention of medical students from underrepresented populations into the careers in patient-oriented research in psychiatry.